Cellular Senescence Network (SenNet) Consortium Organization and Data Coordinating Center (CODCC)

Abstract
The Cellular Senescence Network Consortium (SenNet) presents unique new requirements and opportunities
for organization and data coordination relative to the rapidly growing community of single-cell genomics mapping
consortia including the Human BioMolecular Atlas Program Consortium (HuBMAP), the Human Cell Atlas (HCA)
and the Human Tumor Atlas Network (HTAN). In particular, SenNet focuses on discovery, induction, and
mapping of specific physiology at the cellular and molecular level, under a variety of normal,
experimental and disease conditions, not “just” a catalog of normal, murine, or cancer tissues. This
substantially increases the value of engagement and collaboration among the teams that constitute
SenNet. Specifically, investigators among the Consortium Organization and Data Coordination Center
(CODCC), Tissue Management Centers (TMCs), and Technology Development (TTDs), as well as the broader
community of Cellular Senescence (CS) scientists and innovators, will need to work together to common purpose
to achieve a multiyear strategy of human impact. SenNet will also need senescent cells to cooperate to reveal
their biology. These are an understudied set of cells and phenotypes that are fluid in many ways we do not yet
understand, but yet may have profound impact on our ability to address a variety of conditions with tremendous
burden of disease across organ systems (e.g. neurological deterioration, cancer control, and even aging).
SenNet, distinct from other single-cell genomics consortia, will need more shared focus upon prioritizing
experiments jointly performed and/or replicated among laboratories, prioritizing tight focus on specific cells,
and addressing changes, pathways, and trajectories cells may take over time. SenNet will ultimately require
changing the conception of single-cell -omics maps to include dynamics in time, space and function, and will
feed these back onto the other efforts.

Public health relevance
Project Narrative The Cellular Senescence Network (SenNet) Consortium Organization and Data Coordination Center (CODCC) will engage the rapidly growing community of single-cell genomics mapping consortia including the Human BioMolecular Atlas Program Consortium (HuBMAP), the Human Cell Atlas (HCA) and the Human Tumor Atlas Network (HTAN). In particular, SenNet focuses on discovery, induction, and mapping of specific physiology at the cellular and molecular level, under a variety of normal, experimental and disease conditions. Investigators among the Consortium Organization and Data Coordination Center (CODCC), Tissue Management Centers (TMCs), and Technology Development (TTDs), as well as the broader community of Cellular Senescence (CS) scientists and innovators, will work together to common purpose to achieve a multiyear strategy of human impact.